Pulmonary Fibrosis Regulation by miR-1

Summary/Abstract:
Fibrotic diseases are associated with high morbidity and mortality. Pulmonary fibrosis (PF) is a progressive
disease with no effective treatment except lung transplant. PH is also a risk factor for other health
complications including lung cancer. A major characteristic of PF is increased deposition of extracellular matrix
(ECM) that leads to lung tissue stiffening and loss of function. PF is a heterogeneous disease characterized by
aberrant signaling pathways of oxidative stress (OS), TGFβ, and NF-κB. We have previously reported
increased ROS and activation of MAPK, NF-κB, and TGFβ in alveolar epithelial cells following treatment with
known lung fibrotic toxicants silica and multi-walled carbon nanoparticles (MWCNT). Our previous studies also
showed increased expression of Col3A1 and TGFβ in alveolar epithelial cells in response to MWCNT. While
PF is multifactorial, studies have linked reactive oxygen species (ROS) and aberrant microRNAs (miRs) in lung
fibrosis development. How exactly ROS regulate miRs that drive lung fibrosis development remains largely
unknown and is the focus of the present application. In our study of human alveolar epithelial (A549) cells
exposed to MWCNT, we found that: (1) miR-1 is downregulated; (2) TSP-1 is up-regulated; and (3) exogenous
mimic miR-1 suppresses TSP-1, a major activator of TGFβ. These findings suggest that miR-1 and TSP-1 are
regulated by MWCNT and targeting miR-1 and TSP-1 might inhibit TGFβ-mediated fibrotic response. The
central hypothesis of the current project is that ROS suppress miR-1 which promotes increased TSP-1 and
active TGFβ fibrotic signaling. Specific aims are: (1) determine the mechansims by which miR-1 is regulated;
(2) determine the mechanistic link between miR-1 and fibrotic signaling via TSP-1/TGFβ (or other pathways
emerging from mRNASeq data); and (3) determine the function of miR-1 in lung fibrosis in vivo by analyzing
whether a model of bleomycin- and MWCNT-lung fibrosis in mice and exogenous miR-1 treated mice are less
prone to lung fibrosis than control miR-1 untreated mice. The proposed study will elucidate cellular and
molecular mechanism involved in lung fibrosis by targeting TSP-1 via miR-1. This hypothesis, if proven, will
establish a potential microRNA therapy in pulmonary fibrosis.

Public health relevance
Project Narrative: Pulmonary fibrosis (PF) is a progressive, deadly lung disease and without an effective treatment except lung transplant. The proposed study aims to explore the molecular mechanisms underlying lung fibrosis associated with microRNA. The ultimate goat of the study is to identify potentially a novel therapeutic approach for effective treatment of PF.